Identifying molecular markers that predict relapse after therapy discontinuation inchronic myeloid leukemia.

Clinical outcomes in chronic myeloid leukemia (CML) were revolutionized by development of imatinib (IM)
and later generation tyrosine kinase inhibitors (TKIs) that target the Bcr-abl oncogene. Currently, ~55% patients
with newly diagnosed CML achieve a major molecular response to TKI treatment (MMR) and 17% a complete
molecular response (CMR). Because CML patients survive many years, there is interest in identifying those who
can discontinue treatment. This interest is encouraged by the 30% incidence of side effects in during long term
TKI therapy and the substantial costs of chronic TKI treatment to patients and healthcare systems. Unfortunately,
~60% of subjects with sustained MMR/CMR relapsed after TKI discontinuation in several clinical trials. Given
favorable rates results of TKI re-induction with after relapse, a therapy discontinuation attempt is a part of the
National Comprehensive Cancer Network (NCCN) guidelines for patients with prolonged CMR.
These discontinuation studies suggest some leukemia stem cells (LSCs) persist in remission. Persistent
LSCs do not have mutation or duplication of the BCRABL fusion gene, as is seen with overt TKI resistance, but
provide a reservoir of cells susceptible to acquiring such mutations, or those leading to blast crisis (BC). Current
clinical tools are inaccurate in predicting the likelihood of relapse vs sustained remission post TKI discontinuation.
We developed a murine bone marrow transplantation model to define characteristics associated with
successful TKI discontinuation. In this model, primary recipients of Bcr-abl transduced syngeneic bone marrow
(in chronic phase; CP) were donors to secondary recipients. Secondary recipients were treated with TKIs + other
agents, and mice with an MMR were donors for tertiary recipients. Tertiary recipients were followed without
treatment. We found a 64% relapse rate in recipients of bone marrow from mice with IM-induced MMR that did
not correlate with number of Bcr-abl+ cells from the treated donors or Bcr-abl transcript copies/cell.
In prior studies, we found increased expression of Fap1 (a Fas and Gsk3β inhibitor) contributed to Fas
resistance and βcatenin/survivin activity in CML-LSCs. We found that the addition of an inhibitor of Fap1 or
survivin to IM treatment prevented relapse in Bcr-abl+ bone marrow recipients. Importantly, no tertiary recipients
of bone marrow from IM + Fap1 or survivin inhibitor treated mice relapsed over 24 wks of observation (equivalent
to 15+ human years). We found a 50x increase Bcr-abl transcript copies/GFP+ cell in the bone marrow of mice
treated with IM vs IM + Fap1 or survivin inhibitor. This reflected differences in bone marrow populations in these
mice. In transcriptome analysis of bone marrow from mice treated with TKI + a survivin inhibitor, we identified
differences in pathways involved in positive regulation of the innate immune response, NOD-like signaling,
cytokine production, and regulation of ribonuclease activity.
We hypothesize that identifying pathways which are associated with relapse will permit selection of CML
subjects able to safely discontinue treatment. Such pathways may be rationale therapeutic targets to permit more
subjects to discontinue treatment, or regain an MMR. We will investigate this through two Aims;
Aim 1: Identify molecular markers associated with relapse in CMR-CML patients undergoing a therapy
discontinuation attempt. TKI treatment will be discontinued per NCCN guidelines. A clinical trial will correlate
molecular markers in the subject’s bone marrow with relapse vs sustained therapy free remission.
Aim 2: Define characteristics that predispose to relapse after TKI discontinuation in a murine CML model.
We will investigate molecular mechanisms predisposing to relapse after TKI discontinuation in patient derived
xenografts or murine bone marrow transplants. Implicated pathways will be targeted in pre-clinical studies.
In these studies, we employ a pre-clinical murine model to study TKI discontinuation. Results will be
translated to inform studies in human CML subjects. The goal is to identify pathways associated with relapse
after TKI discontinuation as prognostic indicators and potential future therapeutic targets.

Public health relevance
Chronic myeloid leukemia (CML) is a malignant bone marrow disorder of middle aged and elderly adults. Use of tyrosine kinase inhibitors (TKIs) directed to the Bcr-abl oncogene has prolonged survival in CML. Recent clinical trials determined that a subset of CML patients are able to discontinue TKI treatment and sustain a prolonged remission. However, ~50% of patients relapse after discontinuing treatment and molecular markers associated with relapse vs sustained remission are unknown. The goal of our studies is to identify molecular markers of relapse in human CML subjects undergoing a therapy discontinuation attempt according to standard of care, clinical practice guidelines.